Structure and function of prokaryotic appendages by cryo-electron tomography

DESCRIPTION (provided by applicant): Many prokaryotes use extracellular appendages, notably the flagella and pili, for motility and colonization of biotic and abiotic substrates. Both flagella and pili are well-known virulence factors for numerous pathogenic bacterial species. Here we aim to determine two things: 1) how redundancy of the flagellins in multi-component flagellar filaments alters overall flagellum structure and function, and 2) the structural variatio that exists between several classes of type IV pili at the macromolecular level. To answer these questions, we are using several bacterial species, Vibrio cholerae and Vibrio vulnificus, human pathogens that cause severe gastroenteritis, diarrhea, and death; and Caulobacter crescentus, a well-established non-pathogenic model system. We are using these organisms to build upon our previous structural studies of the polar appendages of C. crescentus and to develop Vibrio species as model systems for structural studies of pathogens. Together, these studies will provide new information regarding the structural and functional diversity of prokaryotic flagella and pili. The three areas to be investigated in this project are: 1. Determine the structural and functional implications of multi-flagellin flagella in pathogenic and non-pathogenic bacteria. Experiments will determine the structure of flagella from wild type and mutant C. crescentus, V. cholerae, and V. vulnificus in situ through cryo-ET of frozen hydrated cells. Cryo-EM and helical reconstruction approaches will define the high-resolution structure of flagella isolated from C. crescentus, V. cholerae, and V. vulnificus. 2. Determine the structures of several classes of type IV pili in intact bacterial cells. Experiments in this aim will determine the in situ structure of he T4bP of V. cholerae and V. vulnificus and Flp-type pili of C. crescentus through cryo-ET and sub-tomogram averaging. We will characterize structural changes resulting from mutants to the pilus filament or pilus complex and their impact on pilus structure, pilin secretion and possible retraction, and complex integration into the cell membrane. 3. Continue the development of cryo-electron tomography technology to generate improved structures of prokaryotes and their appendages. We aim to optimize our newly installed Zernike phase contrast electron microscope for cryo-ET applications. Our goal is to develop ZPC cryo-ET by optimizing the thin films used for Zernike phase plates and developing full automation of biological data collection. In addition, this state of the art technology calls for the development of new software and improvement of already existing algorithms for a more efficient and biologically relevant filtering and 'denoising' of cryo-ET data.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project addresses several questions of critical importance to the success of bacteria that are pathogens of humans and other animals. Many bacteria use appendages, notably the flagella and pili, for motility and colonization of biotic and abiotic substrates. Flagella and pili are structurally complex macromolecular machines whose function is regulated by the sum of each of their individual components. The structural and functional studies proposed will first show how bacteria have developed, in response to environmental pressures, flagella that contain multiple, redundant flagellins and how the incorporation or deletion of these flagellins impacts both structure and function. The second sets of studies have been engineered to determine the structures of two representative forms of the type IV pilus. The specific bacteria being analyzed include two pathogenic organisms that cause gastroenteritis, diarrhea, and death in humans and model non-pathogenic organism. The use of these three different organisms will enable us to draw broad conclusions concerning the structures of the two appendages, which will be applicable to many bacterial species.